Determining the contribution of glutaminase-dependent metabolism of dendritic cells to inflammatory diseases

PROJECT SUMMARY
Dendritic cells (DCs) are professional antigen-presenting cells that initiate T-cell mediated
inflammation or support tolerance to self- and environmental antigens. However, it remains
unclear how DCs are programmed to choose between driving inflammation versus immune
tolerance. During immune activation, DCs profoundly rewire their intracellular metabolic pathways
to perform their functions and interact with T cells. However, the molecular mechanisms
connecting metabolic changes in activated DCs to their immune functions are not completely
understood. We propose that understanding the metabolic processes of DCs during antigen
presentation offers an avenue for the discovery of novel mechanisms of inflammation and immune
tolerance. Research from our group and others has shown that the metabolism of DCs regulates
cytokine secretion and antigen presentation. We showed that DCs highly express the rate-limiting
mitochondrial enzyme Glutaminase (GLS) that converts the most abundant circulating amino acid
glutamine to glutamate. Our new data suggest that GLS is a metabolic checkpoint that controls
DC maturation and activation and enhances antigen-presentation to CD4 and CD8 T cells. The
central hypothesis of this project is that glutamine metabolism in DCs directly controls their choice
during antigen presentation between activating pro-inflammatory T cells and priming regulatory T
cells to establish tolerance. We will capitalize on novel mouse models of GLS deficiency in DCs
and a combination of experimental and systems immunology approaches to identify molecular
mechanisms of how Glutaminase-dependent metabolism in DCs controls inflammation and
tolerance by following two complementary aims. In Aim 1 we will determine how GLS activity in
DCs regulates antigen presentation and inflammation. To this end, we will decipher how GLS
regulates intracellular metabolism, pro-inflammatory signaling pathways, gene expression and
antigen processing and presentation in DCs during activation and maturation. In Aim 2 we will
identify cellular and molecular mechanisms that connect GLS-expressing DCs to inflammatory
diseases. We will determine how GLS and glutamine metabolism reshape the crosstalk between
DCs and T cells in an antigen-driven model of atopic dermatitis and a genetic model of psoriasis.
This project will identify new molecular mechanisms connecting metabolism to antigen-driven
inflammation and direct novel interventions to target GLS in DCs to control pathological
inflammation, allergy, and tissue damage.

Public health relevance
PROJECT NARRATIVE We showed that dendritic cells (DCs) express metabolic enzyme Glutaminase (GLS) to enhance antigen presentation. We will investigate the previously unknown molecular mechanisms of how Glutaminase-dependent metabolism reprograms DCs to enhance immunogenic antigen presentation and inflammation. Finally, we will identify the role of GLS-expressing DCs in T cell polarization and inflammatory and allergic diseases.